Tricuspid Valve Maladaptation: Its Stimuli, its Effect on Valve Function, and itsResponse to Therapy

ABSTRACT. Tricuspid valve regurgitation severely impacts more than 1.6 million Americans. In most patients,
tricuspid regurgitation is considered “functional” or due to valve-extrinsic factors. The valve itself is considered
intact and thus viewed as an innocent bystander. Therefore, most treatment strategies focus on these valve-
extrinsic factors and ignore the valve itself. Recently, we have shown that tricuspid regurgitation may not be so
functional after all. In two separate sheep models of functional tricuspid regurgitation, we showed that the
tricuspid valve leaflets fibrotically remodel, i.e., maladapt. Those leaflets grow in area and become both thicker
and stiffer. Through computational studies, we further showed that maladaptation reduces leaflet compliance
and their ability to successfully coapt, thus impeding valve function. These findings are of critical importance as
tricuspid maladaptation may be a predictor for disease progression and patient outcomes. They may also explain
the limited success of current treatment strategies. That is, they may explain why tricuspid valve repairs fail long-
term in as many as 30% of patients. Finally, tricuspid maladaptation may also serve as a pharmacological target
for future therapies. While others have shown that human tricuspid valve leaflets may remodel in disease by
increasing their area, it has yet to be shown that they also thicken and stiffen. Thus, tricuspid maladaptation has
not been fully confirmed in patients, a knowledge gap that stands between our novel discovery and improved
diagnostic and therapeutic strategies for tricuspid regurgitation. The primary objective of this Administrative
Supplement is to fill this knowledge gap. Specifically, we aim to demonstrate that human tricuspid valves also
maladapt by thickening and stiffening. To this end, we will take an in-vitro approach using donated cadaver
hearts. We will also explore a secondary objective and determine whether those valve properties are age and/or
sex dependent. Thus, our specific aims are: 1) Demonstrate that human tricuspid valves maladapt in disease
via thickening and stiffening; and 2) Test whether human tricuspid valve thickness and stiffness are age- and
sex-dependent. The expected outcome of this work will be two-fold. First, at the conclusion of our work, we will
know whether human tricuspid valves also maladapt. This is critically important to translating our research on
sheep (as funded through the parent R01) to patients. Thereby, the combined work of this supplement and the
parent grant will provide insight into the fundamental pathophysiology of heart valve disease. Additionally, we
may thereby establish tricuspid maladaptation as a novel therapeutic target in patients. Second, we will have
tested whether tricuspid valve thickness and stiffness are sex- and age-dependent. This is highly important to
our understanding of basic valvular physiology/pathophysiology and will also likely inform differential treatment
strategies dependent on patient sex and age. Overall, our effort will shed new light on a deadly disease and
clearly leverages our parent grant with the help of the CAROL Act.

Public health relevance
PROJECT NARRATIVE. Leakage of the tricuspid valve, located between the right atrium and right ventricle, is extremely common and can significantly impact patients' health. We have recently found a new disease mechanism that may explain the failure of current treatment strategies and suggest better ones. However, our discovery has been limited to sheep. The goal of this supplement is to demonstrate the same disease mechanism in humans.